West Virginia University Stroke COBRE

Project Summary
The overall goal of the Administrative Core of the WVU Stroke CoBRE is to provide leadership
and manage the development of a center of excellence in basic and translational stroke research
at West Virginia University (WVU). To achieve this goal, the following specific aims will be
achieved: The thematic research focus area is stroke and the research projects assess linked
areas of the prediction, causes, acute treatment and rehabilitation of stroke. To achieve this goal,
the follow specific aims will be achieved: Specific Aim 1: Develop high quality mentored research
and career development in the WVU Stroke CoBRE. All five research projects emanate from the
research activities of assistant/associate professors in a tenure track appointment in their
respective departments. Aim 1 be achieved by expanding our mentoring program for junior faculty
that addresses the transition to and attainment of independent research funding, with an
emphasis on supporting the professional development of junior faculty. Clear expectations and
milestones for mentees and their respective mentors (both internal and external) are highlighted
in the annually signed mentoring agreement. Specific Aim 2: To hire new faculty with a research
expertise in stroke. The Program Director and Internal Advisory Committee members are well
positioned to direct recruitment of stroke researchers into new positions at WVU. Additionally,
mid-funding cycle graduation of the current group of junior investigators will free up funds to
provide startup packages for new recruits. These strategic appointments have already resulted in
the active recruitment to WVU of 13 new faculty in stroke research in Phase I. Specific Aim 3:
To continue a formative and summative evaluation strategy with specific milestones. Achieving
these aims will launch the JIs as independent scientists in stroke research fields and provide a
foundation of professional development for their long-term academic career success.
Accomplishing these goals will position the WVU Stroke CoBRE to become a national center of
excellence in stroke research that addresses the issue of stroke and its co-morbidities in West
Virginia (WV) and the nation. The CoBRE mechanism will increase the number of stroke
researchers, expand our capacity to programmatically address important issues in stroke and
enhance our vital research cores that serve the stroke, cardiovascular and neuroscience
communities at WVU and across the state while meeting the nation’s need for innovative
approaches to this devastating disease.